Columbia Center for Interdisciplinary Research on Alzheimer's Disease Disparities (CIRAD)

OVERALL SUMMARY
The focus of the Columbia University Center for Interdisciplinary Research on Alzheimer’s Disease
Disparities (CIRAD) is biological, behavioral, sociocultural, and environmental mechanisms of ADRD
disparities, including risk and resilience factors, biomarkers, and caregiving. The CIRAD will assemble
a multidisciplinary team of investigators at the four schools of the Columbia University Medical Center
including the Physicians and Surgeons, Nursing, Public Health and Dental Medicine, the Taub Institute
for Research on Alzheimer’s Disease and Aging, the Columbia University Alzheimer’s Disease
Research Center (CU-ADRC), the Gertrude H. Sergievsky Center, and the New York State Psychiatric
Institute. Additionally, the CIRAD will have partnerships with the Mount Sinai School of Medicine ADRC,
Weill Cornell Medical Center (WCMC), The Einstein Aging Study at Albert Einstein College of Medicine,
Hebrew Home for the Aged at Riverdale (HHAR), the State University of New York – Downstate Medical
Center and the City University of New York. The team includes experts in research in social
determinants of health (SDOH), caregiving and dementia, mental health, physical health, stress,
prevention, behavioral research, observational studies, clinical trials, bioinformatics and community-
based participatory research. CIRAD will partner with community based organizations and members of
the New York City community. The CIRAD team has access to tremendous resources for training in
ADRD disparities research and career development activities that will be provided to the RCMAR
Scientists before, during, and after their pilot studies are funded. The goal of CIRAD is to provide
mentoring and career development, support for pilot studies, training in health disparities, and
interdisciplinary collaboration to investigators from under-represented backgrounds who are pursuing
ADRD research, and to support and accelerate research on the biological, behavioral, sociocultural,
and environmental mechanisms of ADRD disparities so that they can be narrowed or eliminated.

Public health relevance
NARRATIVE The Columbia Center for Interdisciplinary Research on Alzheimer's Disease Disparities will provide mentoring, training, pilot funding, and interdisciplinary collaboration to investigators from under-represented backgrounds in ADRD research, and will accelerate innovative research on the mechanisms of ADRD disparities.